Understanding the clinical impact of cumulative genetic risk to glaucoma

Primary open-angle glaucoma (POAG), the most common glaucoma subtype, is one of the most polygenic
common complex ocular diseases and a leading cause of blindness worldwide. This proposal is aligned with
the NIH roadmap, translating our previously derived POAG polygenic risk score (PRS) into precision medicine
approaches that prevent glaucoma-related blindness. In this study, we propose 3 specific aims. 1) In the initial
funding period, we detected definite+probable POAG in 20.8% of people in the highest decile of glaucoma
PRS versus 2% in the lowest decile after a comprehensive screening exam. We also noted the tool was less
effective in ethnic minorities compared to Europeans. We intend to update the POAG PRS using new cross-
ancestry genomic data and validate it in 4 independent study samples (the UK Biobank, a health professional
case-control study embedded in a population-based sample, and patients from 2 Hospital biobanks). We
anticipate that the new PRS will have better predictive power in ethnic minorities than our original genetic tool.
2) We will test the hypothesis that patients in the highest POAG PRS decile (n=100 subjects) have more
progressive functional and structural optic nerve degenerative changes compared to people in the lowest
decile (n=100 subjects). We also anticipate that those in the highest PRS decile will have a more unfavorable
IOP profile after the water drinking test. 3) Finally, we will develop and validate a genetic test that incorporates
our updated PRS with blended low-pass whole genome-exome sequencing in clinic POAG patients across the
spectrum of disease severity (n=1000 subjects). We will assess the impact of this test on patient perception
and provider management in a CLIA (Clinical Laboratory Improvement Amendments) environment. Overall,
this proposal will provide a robust tool to facilitate glaucoma detection across ancestries. The proposal will also
provide new insights into the utility of the POAG PRS and bring us one step closer to precision care for POAG.

Public health relevance
Primary open-angle glaucoma (POAG) is a highly polygenic ophthalmic disease. A polygenic score (PRS) derived from the cumulative effects of common variants has utility in POAG detection. We will refine the PRS and determine its impact in cross-sectional and longitudinal analyses, translating knowledge regarding the POAG genetic architecture into novel approaches for diagnosing, preventing, and treating this disease.